ADMINISTRATIVE CORE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Biomedical Research Center infrastructure is inherently complex and is comprised of administrative, mentoring, educational, resource, and research components. The goals of the Administrative Core are (1) to evaluate the effectiveness of center programs and cores, (2) to monitor the progress of individual research subprojects, (3) to administer the small grants program, (4) to ensure that all center programs, core components, initiatives, policies and reporting mechanisms are developed, implemented, and administered within federal granting agency policies and deadlines, (5) to provide fiscal oversight of all subprojects and cores, and (6) to provide high-level program and administrative support to Subproject PIs and Core Directors.